Functions of the thalamus in attention and perception

PROJECT SUMMARY
The visual thalamus has been extensively studied in terms of its anatomical organization, connectivity patterns,
and basic neural response properties. However, its role in perception and cognition has remained poorly
understood. The present application is a competing renewal submission for our grant “Functions of the thalamus
in perception and cognition” (RO1-EY017699). Pulvinar is the largest nucleus in the primate thalamus and is
considered a higher-order nucleus, because it forms input-output loops almost exclusively with cortex. In addition
to cortical inputs, pulvinar also receives projections from the superior colliculus (SC) – a midbrain area controlling
saccadic eye movements and spatial attention. From an anatomical perspective, pulvinar is ideally positioned to
regulate the transmission of information to cortex and between cortical areas to influence perceptual and
cognitive processes. Evidence from lesion studies in humans and monkeys demonstrates a critical involvement
of pulvinar in a number of fundamental cognitive functions, including orienting responses and the filtering of
unwanted information. Our studies during the last funding cycle have begun to establish neural correlates that
may underlie some of these functions. By using simultaneous multi-site recordings in fronto-parietal cortex and
pulvinar, we (i) established a link of pulvinar population responses predicting attention behaviors and (ii) defined
a specific role for functional interactions between pulvinar and the lateral intraparietal area (LIP) in regulating
temporal population dynamics during spatial attention. This application extends this work to further a causal role
of the macaque pulvinar in attention control by probing the hypothesis that pulvinar is an integral subcortical part
of a large-scale attention network and that, with critical input from SC, pulvinar operates by coordinating activity
across attentional control centers in fronto-parieto-temporal cortex. Using an integrated multi-modal methods
approach that includes simultaneous multi-site recordings with dense electrode arrays, neuroimaging, reversible
inactivation and behavioral measures in monkeys trained on variants of an Egly-Driver task, we will probe these
ideas by pursuing three specific aims. First, we will systematically characterize attentional modulation and
functional interactions across pulvinar subdivisions as a function of behavioral demands by simultaneously
recording from large neuronal populations. Second, we will probe the idea that pulvinar coordinates interactions
within a fronto-parieto-temporal attention control network, thus acting as a temporal coordinator, in a causal
manner by simultaneously recording from FEF, LIP, PITd and their interconnected projection zones in pulvinar
before and during reversible pulvinar inactivation. And third, we will investigate causal influences of SC on
pulvinar and their effects on pulvino-cortical interactions by simultaneously recording from the aforementioned
network and the SC before and during reversible SC inactivation. The significance of the proposed research is
that it will contribute to a better understanding of pulvinar’s role in a fundamental cognitive operation, selective
attention—the impairment of which has devastating consequences on human health.

Public health relevance
PROJECT NARRATIVE The proposed research aims to advance our understanding of how the brain prioritizes information from cluttered environments to guide visual behaviors. This process, broadly referred to as selective attention, is impaired in several clinical populations, including individuals with spatial neglect after stroke, and in neurodevelopmental disorders such as attention deficit hyperactivity disorder (ADHD), schizophrenia, autism spectrum disorder (ASD) and cortical visual impairment (CVI). By better understanding the separable neural processes that contribute to selective attention, we hope to generate more pointed hypotheses about its dysfunction, leading to more effective treatments and interventions.